ANGIOTENSIN CONVERTING ENZYME INHIBITION IN DIABETIC NEPHROPATHY

This study is designed to assess the impact of blood pressure reduction, with the angiotensin converting enzyme inhibitor ramipril, on the progression of diabetic nephropathy in patients with IDDM.